Hedgehog signal transduction: mechanism of Ci/Gli transcriptional effector activation

Project Summary
This project aims to understand the basic molecular mechanisms of Hedgehog (Hh) signal
transduction in Drosophila. Hh proteins are prominent members of the limited set of extracellular signaling
molecules responsible for directing development and regulating stem cell activity in Drosophila and in
humans. Consequently, genetic alterations to Hh signaling underlie many developmental disorders and
many types of cancer. Pioneering studies in Drosophila identified the central Hh signaling pathway
components, which were later found to be highly conserved in mammals. Those advances led to much
improved diagnosis of several human syndromes and diseases, and to the development of very promising
anti-cancer drugs that target Smoothened (Smo), a key membrane protein that initiates Hh signal
transduction. The Hh pathway culminates in altering patterns of gene transcription by modifying the activity
of the conserved transcription factors, Ci (in flies) and Gli1-3 (in mammals). Deciphering the mechanisms
that connect Smo to Ci/Gli activation is critical to understand Hh signaling and for the development of drugs
that directly target Ci/Gli activity. Such drugs would potentially counter or restore pathway activation
perturbed by any type of mutation.
Hh signaling is extremely sensitive to the stoichiometry of signal transduction components and must
therefore be studied under normal physiological conditions. Drosophila offers the most rapid and incisive
molecular genetic approaches to accomplish this. New insights can then be applied rapidly to Hh signaling
in humans and other mammals because the components and mechanisms involved are highly conserved.
Hh regulates Ci in two ways. Hh blocks proteolytic processing of full-length Ci (Ci-155) to a transcriptional
repressor and it activates Ci-155, opposing inhibition by a direct binding partner, Suppressor of fused
(Su(fu)). The mechanism of Ci or Gli activation is largely unknown, but the protein kinase, Fused (Fu), has a
central role in Drosophila. We aim to understand how Su(fu) restrains Ci-155 activity and how Fu kinase
overcomes this inhibition. Our studies will use extensive resources generated by prior studies: a large set of
CRISPR-derived designer ci alleles, stocks that additionally permit simultaneous genetic alteration of one or
more interacting signal transduction proteins and knowledge of Fu target sites of uncertain functional
importance. We expect to define relevant Fu sites, investigate indications that Hh promotes a transition from
an inactive to an active Ci-Su(fu) complex, and explore whether these regulatory transitions can be
reproduced by relevant domains of mammalian proteins in Drosophila.

Public health relevance
Relevance Many birth defects and a wide spectrum of highly prevalent cancers arise from aberrant regulation of the Hedgehog (Hh) signaling pathway. Most components of this pathway were first discovered in Drosophila and then found to have equivalent roles in mammals, leading to improved diagnoses of human disease and the development of promising anti-cancer drugs. Further progress in addressing these health issues will be spurred by a deeper understanding of the mechanism of Hh signaling, gained from the continued genetic analysis in Drosophila outlined in this project, focused on the key question of how the transcriptional effector of Hh signaling is activated.